Identifying genetic and sociodemographic determinants of susceptibility to infectious diseases in diverse population groups

PROJECT SUMMARY
Racial/ethnic disparities in infectious disease burden are common and can exacerbate existing social
inequalities. Beyond the question of justice, health disparities have major economic consequences that can affect
everyone in society. Previous studies have established the role of both environmental factors (e.g. healthcare
access, socioeconomic status, lifestyle, and structural racism, to name a few) and human genetic factors in
susceptibility to infectious diseases. However, systematic and comprehensive assessment of both
sociodemographic and genetic factors that underlie ethnic/racial disparities in infectious disease is lacking. Filling
this gap is important for both clinical care and public health.
To this end, here we will leverage the genetic, electronic health records, and survey data from the All of US
biobank to test the hypothesis that human genetic factors can contribute to racial/ethnic disparities in infectious
disease burden independently of sociodemographic risk factors through the following aims:
Aim 1: To identify demographic, socioeconomic, behavioral, and environmental factors that contribute
to racial/ethnic disparities in infectious disease prevalence. In this aim, we will perform a comprehensive
assessment of 227 demographic, socioeconomic, behavioral, and environmental variables, collected through All
of US surveys, on the prevalence of 336 infectious disease phenotypes across fine-scale, genetically-defined
population communities. At the end of this aim, we will know which infectious diseases are enriched or depleted
in which fine-scale racial/ethnic communities and which demographic, socioeconomic, behavioral, and
environmental variables are the main contributors to these disparities.
Aim 2: To identify human genetic factors that contribute to racial/ethnic disparities in infectious disease
prevalence. In this aim, we will perform in-depth analyses of genetic variants that can be associated with
infectious disease prevalence. We will use complementary approaches to assess common and rare genetic
variants. This aim will lead to the discovery of novel infectious disease susceptibility loci and risk variants. We
will perform in silico functional analysis to gain insight to the function of these variants.
In the short term, this study will result in identifying sociodemographic and genetic risk factors that underlie
racial/ethnic disparities in infectious diseases and understanding their relative contribution to disease prevalence.
Moreover, this project enhances our understanding of infectious disease biology and the genetic factors that
affect interindividual variability in susceptibility to specific pathogens. In the long term, the results of this project
can help the development of new public health policies or new diagnostic tests or drugs for infectious diseases.

Public health relevance
NARRATIVE The project proposed here is relevant to public health for two reasons. First, it can guide the development of more equitable public health policies for infectious diseases. Second, it can lead to the discovery of novel biomarkers or drugs for infectious diseases which in turn can reduce the burden of infectious diseases.